MINORITY-BASED COMMUNITY ONCOLOGY PROGRAM

The overall goals of the Montefiore-Einstein minority-based NCORP community site are to advance the
diagnosis, prevention, and management of early and advanced cancer by participating in NCORP
trials as a minority/underserved community site, and contributing scientifically and administratively to the
NCORP research bases. This will be accomplished by leveraging the strengths of the Montefiore Health
System (MHS), including Montefiore Medical Center (MMC), which brings strengths in integrated patient
care and innovative health care delivery systems in an academic medical center serving a largely
minority population, and the Albert Einstein College of Medicine and Cancer Center (Einstein), which
brings strength in training and education, and in baslc, translational, and clinical research through its NCI-
designated cancer center. The MMC-Einstein program also brings critical leadership to the NCORP
Research Bases, including ECOG-ACRIN, Alliance, and NRG, including leadership roles at the level of the
group chair's office, scientific committee chair (or co-chair), and protocol chair (or co-chair). Our plans
build upon our long-standing involvement in all aspects of cancer research as a main member of
ECOG for 45 years and an NCI-designated cancer center for 48 years, and a strong history of minority
accrual to cancer treatment trials (about 65%of all patients). MMC serves the Bronx, an urban community of
1.47 million residents, of whom 89% are minorities and 29% live below the federal poverty level. In the
prior funding period we had a strong track record scientific contributions to the NCORP research bases, and
met our accrual targets with exceptionally strong minority participation. In the next funding period, we will
continue our strong leadership in cancer therapeutics (EA2165), expand the spectrum of our activities to
include new programs in cancer imaging and screening (TMIST), cancer control/prevention (EAZ171), and
cancer care delivery research (CCDR). The MMC-Einstein NCORP program is led by faculty with
experience in cancer therapeutics and biomarker research (J. Sparano, MD), precision medicine and
immunoncology (B. Halmos, MD), and CCDR and cancer prevention/control (B. Rapkin, PhD), and is
supported by a cadre of other investigators with a broad range of expertise, some of whom benefited from NCI-
funded K12 training program in clinical cancer research.

Public health relevance
The goal of the Montefiore-Einstein Minority/Underserved National Community Oncology Research Program (MU NCORP) is to advance the prevention, diagnosis, treatment, and management of early and advanced cancer. Our goals are to: 1) accrue at least 80 subjects to trials sponsored by the NCORP research bases (including at least 40 to therapeutic trials), 2) provide scientific and administrative leadership to the ECOG-ACRIN, NRG and Alliance research bases; 3) expand our capacity for cancer care delivery research (CCDR) to include at least 3 active CCDR protocols; 4) train and mentor young investigators in all areas of NCORP research; and 5) contribute expertise in novel methodology to address cancer health disparities, including patient engagement, trial design and outcomes measurement.